Bridge to the Baccalaureate Research Training Program at New Mexico State University

This proposal is a new application for a Bridges to the Baccalaureate Degree (BS) T34 Program (Opportunity
number PAR-22-125) at the New Mexico State University (NMSU), Las Cruces. The program proposes to
serve American Indian (AI) and Hispanic students at two community colleges. These institutions combined
have an enrollment of 4293 AI students and 10,699 Hispanic students (data from academic year 2021-22).
The community colleges are composed of two state-supported community colleges: Dona Ana Community
College and San Juan College in Farmington, NM. Funding for 5 years is requested for programmatic
activities that attract, enrich, enhance preparedness, and advance AI and Hispanic students into
baccalaureate degree programs aligned with the biomedical sciences. The annual goals of this application
are: (i) A series of recruitment/informational workshops will be organized and conducted at the community
colleges by the resident community college partner MPIs. This will introduce >100 AI and Hispanic health
and science majors to research career opportunities in biomedicine and biomedical-related research at
NMSU. (ii) From the student pool in goal (i), 10-15 pre-admitted trainees will visit the NMSU campus each
spring for a one-two day orientation program to prepare for forthcoming summer research experiences. (iii)
From the student pool of goal (ii), 10 trainees will conduct fulltime research with a faculty mentor and
participate in many structured enrichment workshops during 9-10 summer weeks at the campus of NMSU.
Workshops will include: enhancement of computer skills for conducting research and preparing a scientific
poster; discussions of ethical conduct of research; comprehensive laboratory safety training; development of
scientific writing and presentation skills; instruction in reproducibility; academic transfer advisement; and,
financial planning for completion of the B.S. degree; (iv) NMSU research-intensive faculty will serve as
summer research preceptors and as research advisors after students transfer to a BS program at NMSU. (v)
This application proposes to transfer 65% of its summer research participants to BS institutions and to
graduate 65% of the transferees with a BS degree. (vi) The NMSU B2B program will support trainees who
have transferred to NMSU until another appropriate NMSU undergraduate training program (such as MARC)
can accept and further support the trainee. The previous NMSU R25 Bridge Program (2006-2022) has
produced 58 almost exclusively American Indian baccalaureate degrees.

Public health relevance
The purpose of this training program is to increase the numbers of under-represented students (specifically American Indian and Hispanic) from community colleges who pursue baccalaureate and graduate degrees in the biomedical and behavioral sciences. The training program promotes inter-institutional partnerships among New Mexico State University in Las Cruces, NM, and two regional community colleges: Dona Ana Community College and San Juan College in Farmington. The overall programmatic goal is to apply well- integrated developmental activities based on summer and academic year research training to increase student preparation and skills to successfully pursue baccalaureate and graduate degrees in biomedical and behavioral sciences.